Multiscale Analysis of Immune Responses

The goal of this research effort is to understand how various types of white blood cells recognize and respond to the presence of a microorganism or cancer cell in the body, or inappropriately recognize a normal component of the body (an auto-antigen). Our experiments are designed to provide a detailed understanding of how the substances (antigens) making up these microorganisms, cancer cells, or normal self-components, are made visible to the defending cells of the innate (anti-unspecific) or adaptive (antigen-specific) limbs of the host defense system cells and how recognition in infections or malignant cells is linked through complex cell-cell interactions to the induction of protective or self-destruction effector responses. Our previous work has described the events within a cell that bring together the antigen and MHC molecule and the cellular distribution of antigenic complexes within the body (antigen processing and presentation). We are now conducting studies primarily at the cell and tissue level to relate the physiology of antigen recognition to the development of effector function, immune memory, or tolerance and to add to this picture the activities of other cell types such as non-hematopoietic cells like fibroblastic reticular cells (FRCs). By understanding these events, we will be able to determine how best to deliver antigenic substances to stimulate an effective immune response or to interfere with autoimmune reactions and to understand how innate and adaptive components of the immune system participate in host defense under normal and pathological conditions. We previously reported a new method for the direct confocal microscopic visualization in real time of the interactions of T cells and antigen presenting cells in intact lymphoid tissue. These studies showed that individual T cells bind stably to antigen-bearing dendritic cells for several hours before activation-associated events lead to dissociation of the cell pairs and rapid migration of the T cells in the lymphoid tissue. Immunological synapses between T cells and a critical antigen presenting cell (the dendritic cell) were visualized in vivo as was clonal T cell division. This experimental system has now been improved by moving to multiphoton rather than confocal imaging and true intravital observation methods have been developed. We have worked out methods for imaging the bowel, which have allowed us to directly image the interaction of microorganisms with gut epithelium and dendritic cells in the mucosal immune system. Our studies in the small bowel have revealed the dynamic extension of lamina propria dendritic cell processes across the villus epithelium and the capture of lumenal bacteria by these processes. Other studies revealed the movements of B cells in lymphoid tissues and have provided evidence that dendritic cells outside of the follicle are involved in presentation of antigen not only to T cells but also to B cells. Using these new imaging approaches in concert with classical cellular immunological tools such a flow cytometry, we have recently shown that the small adapter protein SAP is essential for sustained interaction of antigen-specific T and B-cells that is needed to produce robust B cell clonal expansion and the development of germinal centers. Surprisingly, the same molecule is unnecessary for effective T cell interaction with dendritic cells, revealing an unexpected dichotomy in the molecular control of antigen-dependent cell-cell interactions involving T cells. New transgenic mice with cells ubiquitously expressing fluorescent proteins are being generated to provide new tools for long-term tracking of cells and genetically engineered strains of mice that have fluorescent reporters under the control of cytokine gene regulatory elements are being employed to relate the physical behavior of immune cells to their function.